Physician Assistance Technology in Image-guided Robotic Intervention of Prostate

Recent advances in the multi-parametric MRI of the prostate have led to a surge in new
research methods for the detection and diagnosis of prostate cancer - with the goal of accurate risk-
stratification of prostate cancer. Specifically, a traditional Transrectal Ultrasound (TRUS)-guided
biopsy tends to fail, as samples are randomly collected from the prostate without aiming at
suspicious lesions often visible in MRI. Currently, several new MRI biopsy approaches have come
to the forefront. They are being evaluated and adopted in clinical practice, including in-bore MRI-
guided biopsy and TRUS-guided MRI-fusion biopsy, collectively called ‘MRI-targeted biopsy.’ While
recent literature shows that MRI-targeted biopsies can detect more clinically significant cancer than
a conventional TRUS-guided biopsy, there is still a substantial issue with the precision placement of
the needle in these procedures particularly in transperineal approach, resulting in clinicians being
overly conservative with the amount of tissue removal (Zhang et al., 2019). Need to address needle
placement accuracy in transperineal biopsy is further heightened lately as the fluoroquinolone-
resistant Escherichia coli is becoming a significant concern in public health, and clinicians are
shifting to use transperineal biopsies to avoid post-biopsy infections and overuse of antibiotics.
Literature, as well as our preliminary studies, found that needle deflection is a substantial obstacle
for precision aiming in transperineal biopsies. Abundant literature on needle deflection analysis,
needle steering, and image-guided robots are available in pre-clinical engineering studies. Yet,
clinically viable or proven solutions to address the needle deflection is yet to be seen. Therefore, the
objective of this application is to develop and test a cooperative robotic intervention with closed-loop
error compensation in MRI targeted biopsies and focal therapies, resulting in more precisely
targeted instrument placement. Accurately, we will aim to address needle deflection by the synergic
use of advanced imaging and robotics. Guided by robust preliminary data, this objective is achieved
by pursuing three specific aims: 1) We will develop novel tracking techniques and clinically deploy a
cooperatively controlled, hands-on robotic needle placement manipulator to enable fine instrument
control at the periphery of the MRI bore. 2) We will test the usefulness of a cooperatively controlled
robot to increase the accuracy of needle placement in animal studies mimicking MRI-guided
biopsies of the prostate. Our approach is innovative in its application of novel cooperative robotic
control, in which the clinician maintains ultimate control with the direction of motion being
autonomous to ensure the desired path is followed to the intended target. The proposed study is
also clinically significant since the completion of this current engineering study will enable machine-
assisted semi-autonomous percutaneous therapy, much discussed in the recent editorial article in
Science Robotics (Yang et al., 2018). The impact of the study reaches beyond MRI-targeted
prostate intervention; the technology developed can be translated into other forms of MRI-guided or
ultrasound-guided intervention.

Public health relevance
This proposal aims to develop novel percutaneous robotic devices that will lead to a higher instrument placement accuracy and maneuverability, currently a major impediment to successful MRI-targeted interventions. The proposed research has relevance to public health because the devices will have a positive impact on the treatment of cancers in the pelvis. The work is also thematically aligned to the NIH precision medicine initiatives, as we propose to develop and apply precision treatment tools with the imaging phenotype for treatment guidance.